Sidney Kimmel Cancer Center LAPS Institutional Collaboration

ABSTRACT
The overarching goal of the Sidney Kimmel Cancer Center (SKCC) is to leverage research expertise to reduce
the overall incidence, burden, and mortality from cancer in Greater Philadelphia and beyond. SKCC goals are
realized through unique strengths in addressing cancer problems through collaboration across basic, clinical,
and population research disciplines. SKCC is a NCI-designated cancer center nucleated at the Jefferson
Health-Center City campus and enriched by fully integrated research components at Jefferson Health-Abington
and Jefferson Health-Aria. Building on these strengths, SKCC focuses on addressing catchment area needs
through nurturing transdisciplinary research, expanding innovative research capabilities, extending outreach
and clinical research into the community, and enhancing the pace of bench-to-bedside discovery. The
Jefferson Health system has expanded over the last 3 years and now includes a system of 12 Hospitals
treating more than 8,000 new cancer cases annually. The SKCC catchment area includes Philadelphia,
Montgomery, and Delaware counties in Pennsylvania, and Camden County in New Jersey. Philadelphia's
highly diverse population, with numerous socioeconomic, racial, and health challenges characteristic of major
northeastern cities, shapes SKCC research priorities and outreach. At any given time, hundreds of research
studies are underway at the cancer center, ranging from basic laboratory research to clinical assessments of
new treatments to meet the needs of this diverse population. Many of these studies are collaborative, involving
other cancer centers or other partners in industry and the community. The overall objective and goal of this
proposal is to enable SKCC to participate as a Lead Academic Participating Site (LAPS) in the NCI National
Clinical Trial Network (NCTN) Clinical Research Program. This goal will be achieved through providing
scientific leadership for development and execution of NCTN trials complemented by an integrated and
collaborative research program. The SKCC has an established and well supported infrastructure to nurture
discoveries and processes that advance our fundamental knowledge of cancer biology and implementing them
into the community. As an NCI-designated Cancer Center, SKCC addresses the cancer needs of a diverse
population through integration of laboratory and population-based clinical research, engagement of the
community in relevant research to identified challenges, outreach, and education regarding clinical trials. We
propose the following specific aims in this LAPS application: Specific Aim 1: Deliver and enhance access to
the most advanced cancer care through participation and dissemination of NCTN initiatives including trials for
rare tumors across the SKCC. Specific Aim 2: Promote and support the scientific leadership within the
NCTN. Specific Aim 3: To foster junior faculty investigators' career development through NCTN participation
in both NCTN/NCI committee engagement and as key contributors to conceptual protocol designs.

Public health relevance
Narrative The Lead Academic Participating Site (LAPS) funding opportunity is intended to provide infrastructure support for the conduct of national clinical trials through the National Clinical Trials Network (NCTN). The overall objective and goal of this proposal is to enable SKCC to participate as a Lead Academic Participating Site (LAPS) in the NCI National Clinical Trial Network (NCTN) Clinical Research Program. This goal will be achieved through providing scientific leadership for development and execution of NCTN trials complemented by an integrated and collaborative research program.